Cellular and circuit mechanisms underlying APOE-4 effects on olfaction.

PROJECT SUMMARY:
Understanding the relationship between risk factors and early symptoms is crucial to early and differential
diagnosis of Alzheimer’s disease (AD). Expression of the -4 allele of human apolipoprotein E (APOE-4) gene,
the strongest genetic risk factor for development of the episodic late-onset AD, associates tightly with the
earliest AD symptom - olfactory deficit (OD) in humans. Animals expressing the human APOE-4 gene evince
OD symptoms before AD pathogenesis, indicating a role of APOE-4 in functional disorders of the olfactory
system. However, the pathophysiological mechanisms underlying the APOE-4 effects on olfaction remain
unclear. We hypothesize that APOE-4 dysregulates neural circuits leading to excitation-inhibition imbalance
and neural hyperactivity in the anterior olfactory nucleus (AON) to cause OD at the early stage of AD based
on the following evidence. First, the hallmark AD pathologies appear in the AON in the Braak stages 0 and I
of the disease and increase with AD severity. APOE-4 elevates AD pathogenesis. Second, the severity of AD
pathology (especially tau hyperphosphorylation) in the AON correlates linearly with the copies of APOE-4
allele. Third, AON has direct interconnections with the olfactory bulb, piriform cortex, hippocampus, amygdala,
and lateral entorhinal cortex. All these olfactory centers exhibit vulnerability to AD pathogenesis at early
stages in humans and neuronal hyperexcitability in transgenic animals with humanized APOE-4 genotype.
Based on our preliminary data and the massive interconnections of AON with all other olfactory brain centers
via glutamatergic transmission that is particularly susceptible to detrimental effects of APOE-4, we
hypothesize that APOE-4 causes excitation-inhibition imbalance in the AON and dysfunction of related neural
circuits leading to OD. Three specific aims are proposed to test our central hypothesis. Aim 1: Determine
APOE-4 impact on olfaction-dependent behaviors. Aim 2: Investigate APOE-4 effects on AON neuronal
excitability. Aim 3: Characterize APOE-4 influence on synaptic processing in the AON. The proposed work is
designed to fill gaps in our knowledge on the mechanistic relationship between APOE-4, a well-established
genetic risk factor of LOAD, and OD at the cellular, circuit, and behavioral levels. Our findings will potentially
shed light on development of effective strategies for early and accurate diagnosis of AD in the APOE-4-
carrying or even broader populations. Since AD progressively impairs patient’s cognitive and other mental
abilities for years to decades thus significantly compromises the quality of life in the senior populations in the
US and worldwide, early and accurate diagnosis of this neurodegeneration will significantly benefit the
affected populations and their societies at the medical, economical, emotional, and social levels.

Public health relevance
Project Narrative Due to the lack of approaches for curing Alzheimer’s disease (AD) or slowing down its progression, identifying risk factors or preclinical symptoms and understanding the mechanisms underlying their interactions are of critical importance to early diagnosis and preventative effort. This project aims to reveal the pathophysiological mechanisms underlying the APOE-4-induced olfactory deficit at the anterior olfactory nucleus level and potentially sheds light on developing new approaches for early diagnosis of AD.